Event-Level Analysis of Alcohol Use and Bystander Behavior in Social Drinking Contexts: A Novel Approach to Inform Alcohol-Related Sexual Assault Prevention

Project Summary
The long-term objective of the proposed K08 Mentored Clinical Scientist Research Career Development Award
is to support the applicant in building an independent program of research. The applicant is dedicated to a
career as a clinical scientist with a research focus on the examination of risk and protective factors for alcohol-
related sexual violence and bystander behavior. Ultimately, she aims to conduct research that will inform
violence prevention efforts to reduce the occurrence of alcohol-related sexual assault and its associated public
health burden. Her career development plan has been tailored to expand upon her interests and training to
date and launch her career as one of the few experts in the growing research area of bystander alcohol
intoxication. Through the unique training experiences made possible by this award, she will develop expertise
in qualitative methods and analysis, intensive longitudinal data collection, and advanced statistical analysis for
multilevel data. These skills will be solidified over the course of a 5-year training plan, which involves mentored
training experiences (including guided readings, manuscript development, grant writing, meetings) and
independent training activities (including coursework, seminars, workshops, and presentations). Members of
the mentorship team are experts in their respective fields and their complementary expertise will address
distinct training needs of the applicant. Brown University’s Center for Alcohol and Addiction Studies in the
School of Public Health provides an exceptional training environment with an extraordinary record of research
and an impressive history of successfully mentoring early investigators through the transition to independence.
The primary objective of the proposed research project is to answer key questions about bystanders in drinking
contexts. Bystander-focused sexual violence prevention has proliferated in the last decade, though a
consideration of the importance of bystander alcohol use has emerged much more recently. Alcohol use—one
of the most robust predictors of sexual assault—is commonly present when bystanders have an opportunity to
combat sexual assault risk. The proposed project will use weekend morning reports about the prior evening to
elucidate the event-level effects of bystander alcohol intoxication and related contextual predictors on
bystander outcomes. Focus groups will be used following completion of the weekend morning reports to
deepen understanding of the quantitative results and inform bystander-focused sexual violence prevention.
The proposed award is consistent with training and research priorities of NIAAA’s strategic plan, including
cultivating a talented and diverse research workforce to advance the frontiers of scientific knowledge and
continuing to support research with implications for alcohol-related violence prevention.

Public health relevance
Project Narrative Bystander-approaches to sexual violence prevention are increasingly common on college campuses, yet there is a need for research to understand the real-world situational factors that promote bystander behavior. The current study will use weekend morning reports to answer key questions about the within-person effects of alcohol intoxication and situational context on bystander behavior in social drinking contexts. Results from morning reports and focus groups will be valuable for the refinement of situational models of bystander behavior and the improvement of empirically-informed bystander-focused sexual violence prevention.